IGF::OT::IGF OTHER FUNCTIONS - EXAMINING PATTERNS OF UTILIZATION AND SPECIFIC CARDIOVASCULAR HEALTH OUTCOMES OF SELECT TYROSINE KINASE INHIBITORS FOR LEUKEMIA TREATMENT IN THE ELDERLY POPULATION.

Gaining initial insight about the use of molecularly targeted therapies (MTTX) through proposed patterns of care study.